COGNITIVE FUNCTIONING & QUOFL FOLLOWING GAMMA KNIFE SURGERY FOR BRAIN METASTASE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. This project attempts to evaluate the quality of life and neurocognitive function of brain metastasis patients following Gamma Knife surgery (GKS).